Rapid 3D Ultrasound Tomography Reconstruction Methods for Guided Interventions

Project Summary/Abstract
Background: As a portable non-radioactive modality, ultrasound has been increasingly used in guided interven-
tions such as biopsy and surgery procedure in breast, prostate, brain, face and neck. Current 2D handheld ultra-
sound and 3D Automated Breast Ultrasound System (ABUS) both use only ultrasound reﬂection data to generate
images. 3D Ultrasound Computed Tomography (USCT) was developed to use both reﬂection and transmission
data to provide improved image quality and potentially better diagnostic value.
Challenge: USCT image reconstruction presents a historical challenge of heavy computational complexity, due
to its non-linear, non-convex nature. To our best knowledge, all existing USCT algorithms with high ﬁdelity are
iterative, optimization-based, and thus suffer a heavy computation load. This computation load is especially
cumbersome when higher number of transducers are added to the system to obtain more anatomical information.
Therefore, there is an urgent need to develop an USCT imaging method to provide high ﬁdelity and high speed
at the same time to satisfy the requirement of guided intervention.
Method: We hypothesize that boundary control method will achieve non-iterative USCT image reconstruction,
leading to signiﬁcant increase in computational efﬁciency while warranting ﬁdelity and robustness to noise. This
idea has been mathematically proven and validated by our preliminary research with a 10-fold increase in com-
putation speed while maintaining high ﬁdelity level. The developed method will serve as an ideal non-radioactive
intra-operative imaging guide, and bring new perspective to USCT imaging reconstruction algorithm research. Al-
though this project is not intended for clinical use, we will perform a virtual clinical trial to systematically evaluate
the developed system with computationally simulated phantoms, 3D-printed phantoms, and digital patient-based
phantoms.
Impact: Upon completion, this work will have achieved a computationally light, high-ﬁdelity, near real-time 3D
USCT imaging system, ideal for guided intervention. This system has the potential to:
· Efﬁciently support considerably more transducers without compromising image quality.
· Enable portable USCT to provide powerful tools for guided intervention and other clinical applications.
· Lead to genuine real-time 3D USCT imaging and inspire new applications of USCT.

Public health relevance
Project Narrative Ultrasound computed tomography demonstrates high potential to be utilized in guided intervention such as biop- sies and surgeries. Current image reconstruction algorithms are insufﬁcient to provide both high ﬁdelity and high speed to satisfy the requirement of guided intervention. This work proposes an image reconstruction method for ultrasound computed tomography using direct analytic reconstruction formula to achieve high computational efﬁciency, high accuracy and high robustness to serve as an ideal intra-operative imaging guide.